Innovating Measurement of Youth Social Media Activity: An Approach for Using a Large Language-Based Computer Vision Model to Study What Youth Are Doing on Social Media and Links to Mental Health

Project Summary/Abstract
A rise in rates of depressive symptoms and self-injurious thoughts and behaviors (STBs) and youth using
social media over the past decade have raised alarms about the potential role of social media (SM) in youth
mental health. However, SM platforms include opportunities for a wide range of SM activity, such as creating
content, viewing content, and direct messaging, etc., and youth are able to transition rapidly between
potentially detrimental and beneficial SM activity over the course of minutes. Theoretical and empirical work
suggest that engaging in some types of SM activity, such as viewing self- or peer-related posts, may contribute
to negative SM experiences such as heightened emotional responses to SM, digital feedback seeking, and
social comparison and increase risk for depressive symptoms and STBs. On the other hand, some types of SM
activity, such as direct messaging, may be associated with positive SM experiences such as social
connectedness and decreased risk for depressive symptoms and STBs. Yet, prior research on youth SM use is
characterized by methodological limitations such as retrospective, self-reported, and general measures of time
that are weakly associated with objective measures and do not capture the range of potentially negative and
positive types of SM activity. One recent methodological approach, referred to as screenomics, addresses
some limitations of prior research by capturing high frequency screen images to obtain an objective,
comprehensive record of youth SM activity in real time. However, a screenomics approach is not yet available
at a large scale, given that it yields up to thousands of screen images per participant, and studies have relied
on humans to manually code each image. The overall goal of this project is to address methodological gaps
in the field of SM and youth mental health research by developing and validating a novel approach for
using artificial intelligence computer vision models that can be used to advance objective, ecologically
valid, and nuanced measurement of detrimental and beneficial youth SM use in real time as it naturally
occurs in daily life. Specifically we aim to (1) develop an approach that uses a multimodal large language
model–based computer vision model to accurately identify types of SM activity from youth SM screen images
and (2) investigate the validity of objective measures of SM activity obtained from screen images by showing
that these measures uniquely predict, over and above daily self-report measures of SM activity, negative and
positive SM experiences, depressive symptoms, and STBs (i.e., investigate incremental and predictive
validity). To accomplish project aims, we will focus on a popular SM platform (Instagram). We will (1) consult a
youth research advisory board to help inform study procedures and (2) recruit 50 youth (ages 14–16) with a
range of depressive symptoms to submit daily screen recordings of Instagram sessions and surveys
measuring self-reported SM activity, SM experiences, depressive symptoms, and STBs over 21 days total
(three 7-day periods spaced 1 month apart).

Public health relevance
Project Narrative This project has the potential to develop an artificial intelligence computer vision methodology that can be used to advance an objective, ecologically valid measurement of youth social media (SM) use as it naturally occurs in daily life and can be used in large-scale research. This project lays the foundation for future research de- signed to rigorously investigate bidirectional associations between SM use and mental health in youth. Find- ings from this area of research will help to inform (1) identification of aspects of SM use that may increase or protect against risk for mental health problems among youth, (2) aspects of SM that may serve as targets for mental health interventions, and (3) practice and policy recommendations for youth SM use in adolescence.